Internet-Based Lifestyle Intervention to Eradicate Obese Frailty in Prostate Cancer Survivors (iLIVE)

Over 1 million men in the U.S. are receiving androgen deprivation therapy (ADT) to prevent prostate cancer
progression. Although a critical therapeutic strategy, ADT increases the risk of frailty, weight gain and obesity
in prostate cancer survivors (PCS). In our recent study, the odds of PCS having both obesity plus frailty, i.e.,
obese frailty, were 19x higher in ADT users compared to non-users and obese frailty was a significant and
stronger predictor of recurrent falls than frailty alone. Thus, interventions are urgently needed to mitigate the
obese frailty in PCS that threatens independence and quality of life and which multiplies health care costs.
However, there are currently no effective interventions in clinical practice for PCS that target obese frailty as a
clinical endpoint. Given that the number of PCS on ADT is growing by over 30,000 each year, there is a critical
need to develop scalable interventions with high reach potential to address this urgent practice gap and rising
public health issue. The co-principal investigators for this application each have strong prior work
demonstrating efficacy for reducing obesity via online dietary intervention and frailty via online supervised
resistance training, respectively. The urgent need to address obese frailty in PCS on ADT now supports
combining these interventions into a single, scalable online program. To advance this work toward clinical
practice, our strong multidisciplinary team of experts in nutrition, exercise science, urology, oncology,
behavioral theory, health economics, and implementation science, proposes a 2-arm parallel group
randomized Type I hybrid effectiveness-implementation trial focused on obese frailty in PCS on ADT. This
design allows formal testing of the effectiveness of a combined online, self-directed weight loss + group-based
resistance training program (Internet-Based Lifestyle Intervention to Eradicate Obese Frailty in Prostate
Cancer Survivors: iLIVE) against usual care with obese frailty as a primary endpoint. Our Primary Aim is to
compare iLIVE to UC on obese frailty in 250 PCS on ADT over a 6-month period. Secondary Aims are to: a)
Compare the effect of iLIVE to UC on secondary outcomes, e.g., individual frailty criterion, dietary quality,
physical function, quality of life; b) Assess the durability of iLIVE to UC by comparing groups at 12-month
follow-up; and c) Explore potential moderators (e.g., age, race, BMI) associated with intervention effectiveness.
Finally, our Tertiary Aim is to: Assess key implementation outcomes (e.g., cost, acceptability) to guide future
research regarding the implementation of iLIVE into the clinical care pathway. iLIVE builds on a solid
foundation of diet and exercise interventions in cancer survivors with proven efficacy, and the proposed Type I
hybrid effectiveness-implementation trial is designed to speed effectiveness testing and optimization and
ultimately enable reductions in morbidity and mortality for over 1 million older PCS across the nation.

Public health relevance
Relevance Nearly half of the 3 million prostate cancer survivors in the U.S. were prescribed androgen deprivation therapy that increases their risk of becoming obese and frail. The proposed study determines whether a combination of a web-based lifestyle management program plus online supervised group resistance training can reduce obese frailty. We will also collect preliminary data on a set of implementation outcomes to guide future research testing the implementation of iLIVE into the clinical care pathway